The broken drug supply chain: The impact of COVID-19 on drug shortages and Veteran health

Background: Few of the drugs Veterans take as a cornerstone to prevent and treat disease are produced
domestically; the majority of medications consumed in the U.S. are produced in foreign facilities. Thus, the drug
supply chain is global and susceptible to disruption due to unanticipated events, such as the 2019 Coronavirus
pandemic (COVID-19).
Significance: However, little is known on the frequency of drug shortages causing medication treatment gaps
and subsequent impact on adverse clinical outcomes. This is especially true in the outpatient setting, where
the majority of drug shortages occur.
Innovation and Impact: The research is innovative by conducting formative work on: 1) the impact of the pan-
demic on drug supply and outcomes, 2) differences in shortages in VA priority groups, 3) incorporating stake-
holders to inform methods, 4) direct involvement of VA operations and an expert panel of federal partners, and
[unique access to operations data.]. The majority of Rx use and drug shortages in VA occur in outpatients, but
prior research on drug shortages has focused on inpatients. We will also evaluate the impact of drug shortages
by race, ethnicity, age, location, and co-morbidities. The results obtained here will guide VA policy-makers in
the identification of the most effective policies to address this growing problem.
Specific aims: 1) Determine the impact of the COVID pandemic on the drug supply chain in VA; 2) Assess the
impact of drug shortages on outpatient medication treatment disruption in the VA; and 3) Determine the asso-
ciation between drug shortage-related treatment disruption in outpatient prescription refills and serious adverse
clinical outcomes.
Methodology: Drug supply chain issues will be identified through U.S. reporting systems (e.g., FDA). We will
leverage VA data for the quantity of drugs ordered and supplied nationally using VA purchasing and outpatient
prescription data. For each drug potentially used in the outpatient setting with a reported supply chain issue,
purchase changes will be assessed monthly pre- (2017-2019) and during the pandemic. Aim 1 will use inter-
rupted time series (ITS) analyses to test whether the incidence of supply chain issues triggering a decrease in
supply increased after pandemic start. Aim 2 will identify outpatient drug shortages leading to treatment disrup-
tion using ITS and structural break models. Aim 3 will define cohorts based on the indication for drugs with
identified shortages using a time to event analysis with entropy balance weighting to evaluate if adverse out-
comes (hospitalizations, death, emergency/urgent care) were greater for patients using drugs affected by short-
ages (the exposed group) compared to unexposed controls.
Next steps and Implementation: Dissemination will be guided by an expert panel comprised of VA operational
partners, other federal partners and experts in drug supply and shortages. The quantitative results will be as-
similated with the expert panel discussions to develop a support guide to mitigate drug shortages in VA. The
next step will be to; 1) inform the US list of essential medicines and criteria for production (e.g., domestically)
and 2) determine effectiveness of our support guide and future VA policy implemented based on our work. Our
future research will work to ensure access and equitable distribution of drugs with limited supply and/or at risk
for shortages. Even after the pandemic, the research proposed will provide results to mitigate drug shortages
which remains a crucial public health issue even in the absence of a national emergency. Thus, this will be one
step in our long-term goal to plan for future global emergencies, drug shortages at large, and inform national
policy to decrease the impact of drug shortages on patient outcomes.

Public health relevance
The drug supply chain is global and susceptible to disruptive unanticipated events, such as the 2019 Corona- virus (COVID-19) pandemic, but the impact of drug shortages during a global public health emergency and the impact on Veteran drug supply and health outcomes are unknown. The proposed research is relevant to Veteran health because policy-makers need real world evidence to plan for future global emergencies, drug shortages at large, and inform VA policy to decrease the impact of drug shortages on Veteran outcomes. Thus, this project is relevant to the priority areas of HSR&D, VA operations, and other federal initiatives to provide timely response to critical questions, ensure the availability of safe and effective drugs to our Vet- erans, measure drug shortages and their impact on patient safety, improve resiliency of the drug supply chain, and achieve health equity, especially in VA priority groups.